Genetic approaches to address oligodendrocyte progenitor cell diversity

Abstract
Oligodendrogenesis is a complex process that requires changes in transcription factor expression for the
generation, expansion, and differentiation of oligodendrocyte progenitor cells (OPCs) into mature
oligodendrocytes (OLs) that produce myelin. The overall goal of this proposal is to focus on understanding the
diversity of the OPC stage in the process. Our gene expression screen to identity novel OPC markers revealed
the homeobox gene Gsx1 exhibits temporal expression in OPCs during development. Here we propose to
develop new mouse models to address the role of Gsx1 in OPC biology. In the first aim, we will test if Gsx1 is a
stage specific regulator in OPCs and generate an OPC specific conditional mutant to determine if altering Gsx1
gene function causes changes in OPC expansion, OL differentiation, and/or myelination. We will also test if the
closely related gene, Gsx2, compensates for the loss of Gsx1 in OPCs. In the second aim, we will test if sustained
Gsx1 expression throughout OL development promotes OPC generation and subsequently OL differentiation
and myelination using a temporally controlled doxycycline regulated gain-of-function model. In the third aim, we
will utilize the Gsx1 lineage to reveal OPC diversity during postnatal oligodendrogenesis by generating a novel
Gsx1 reporter allele using Timer Fluorescent Protein. These studies will identify the specific roles of Gsx1 during
the OPC stage of OL development and provide new mouse models key for understanding the complex regulation
of OPCs during oligodendrogenesis.

Public health relevance
Project Narrative The research described in this proposal will develop new genetic tools to study oligodendrocyte progenitor cell development. Specifically, we will generate new genetic loss of function, gain of function, and reporter mouse models to test a role for the homeobox transcription factor Gsx1 in oligodendrocyte progenitor cells during early stages of oligodendrogenesis. These studies will further our understanding of genetic diversity during early oligodendrocyte development and also provide crucial tools for future studies focused on Gsx1 dependent mechanisms driving the generation of oligodendrocyte progenitor cells.